Motor learning of fall resistant skills from laboratory-induced falling among people with Alzheimer's disease

ABSTRACT
The long-term objective of this research is to develop an effective approach that can reduce falls for people with
Alzheimer’s disease (AD) and related disorders. This project’s overall goal is to systematically examine if people
with AD can acquire fall prevention skills from a novel paradigm - perturbation training. The specific aims of
this proposed project are (1) to test if people with AD can adapt to perturbations on a treadmill and learn fall
resistant motor skills; (2) to inspect if people with AD can retain motor skills learned in Aim 1 for at least 6
months; and (3) to determine if people with AD can generalize fall resistant skills gained on the treadmill to
overground perturbations and daily living conditions. We will use a two-arm randomized, controlled
longitudinal design to achieve these goals. A group of 30 older adults with mild AD will be randomized into two
groups: A (training) and B (placebo). Group A will undergo a perturbation training-based motor learning
session including 20 slips (S1-S20) and 20 trips (T1-T20) on a special treadmill. These perturbation trials will
be mixed with regular walking trials in random order. Group B will walk on the treadmill with no perturbations
for the same time as group A. Then, both groups will be exposed to a sudden overground slip (initial overground
slip) and trip (initial overground trip). Participants will return for a retention session 6 months later to undergo
another treadmill slip and trip (treadmill reslip and retrip) followed by an overground slip and trip (overground
reslip and retrip). The perturbation outcome (fall or non-fall) and dynamic stability will be determined for slip
and trip trials. Self-reported real-life falls over 6 months after the learning session will be collected for both
groups. The primary outcome is the binary perturbation outcome following either the slip or trip. Dynamic
stability during slips and trips and the all-cause falls in daily living will be our secondary variables. The primary
outcome and dynamic stability will be compared between S1 and S20 and between T1 and T20 within group A to
test if people with AD can adapt to large-scale slips and trips (Aim 1). To determine whether people with AD
can retain the skills learned in Aim 1 for at least 6 months (Aim 2), the primary outcome and dynamic stability
on treadmill reslip and retrip during the retention session will be compared between groups. The primary
outcome and dynamic stability will also be compared between groups on the overground slips and trips during
the acquisition and retention sessions to test if people with AD can immediately transfer the skills learned in
Aim 1 to overground and if this transfer can maintain for 6 months (Aim 3). In addition, the prospective falls
will be compared between groups to verify if people with AD can transfer the acquired fall resistant skills on the
treadmill to everyday living conditions (Aim 3). Perturbation is a promising modality to prevent falls for people
with AD due to its inherent natures: safety, task-specific, and implicit learning process. This project will have a
profound impact on people with AD and society.

Public health relevance
NARRATIVE Falls are a serious public health threat among older adults, and Alzheimer’s disease significantly heightens the risk of falls and resulting injuries in older adults. The proposed project will address this major public health threat by systematically determining whether people with Alzheimer’s disease can learn fall-resistant skills from perturbation training. Given its attractive inherent features, such as safety, task-specificity, and implicit learning process, perturbation training could be an effective and efficient modality to prevent falls in people with Alzheimer’s disease and related disorders.